06 High Resolution Electron Microscopy Facility

PROJECT SUMMARY: HIGH RESOLUTION ELECTRON MICROSCOPY FACILITY (HREMF)
The mission of the High Resolution Electron Microscopy Facility (HREMF) is to provide high-quality, affordable
electron microscopy services to research investigators at MD Anderson Cancer Center. The facility is in the
Smith Research Building and houses a JEOL JEM 1010 transmission electron microscope, a JEOL JSM 5900
scanning electron microscope, a TechnoTrade coating system, a Leica ultramicrotome, and a Leica
ultrastainer. Dr. Robert Langley has directed the HREMF for the past 10 years and has 20 years of
experience in microscopic imaging of tissues and cells. Kenneth Dunner, Jr, is the manager of the HREMF
and is responsible for the daily operations of the facility, including processing and imaging of samples. The
HREMF houses the only scanning electron microscope on campus and the only transmission electron
microscope that is dedicated to research applications. Since its inception in 1997, the HREMF has received
approximately $500,000 in capital equipment funds from MD Anderson. In grant Yr42, 89% of the total usage
of the HREMF was by peer-reviewed funded faculty, and we are requesting 55% of the HREMF budget from
the CCSG ($106,740). During the past 6 years, the HREMF has provided 6759 hours of service to 164
investigators, 132 of whom were cancer center members representing all 16 CCSG programs. Usage was well
distributed among the CCSG programs, and no program accounted for more than 15% of the HREMF's
resources. The facility also ranked near the top of a user satisfaction survey and made regular contributions to
high-impact publications. The HREMF contributed to 124 publications in peer-reviewed journals, with 88
publications (71%) in journals with IF >5 and 31 publications (25%) in journals with IF >10, including Nature (5
articles), Nat Cell Biol (3 articles), Nat Commun (2 articles), Cancer Cell, Nat Immunol, and Nat Nanotechnol.
The HREMF's Specific Aims are: Aim 1: To provide MD Anderson Cancer Center investigators with access to
microscopy instruments necessary to perform research at the ultrastructural level. Aim 2: To provide complete
electron microscopy specimen preparation services. Aim 3: To provide technical assistance and consultation
for electron microscopy applications.